The 6th Annual International PTEN Symposium: From Patient-Centered Research to Clinical Care

Project Summary: The 6th Annual International PTEN Symposium: From Patient-Centered
Research to Clinical Care will review the latest scientific and clinical advances in PTEN
hamartoma tumor syndrome (PHTS), a rare genetic condition caused by germline mutations in
the PTEN gene that is associated with an increased risk for certain cancers and benign growths
and is one of the most common etiologies for neurodevelopmental conditions, including autism
spectrum disorder. Presented by Cleveland Clinic’s Genomic Medicine Institute and Center for
Personalized Genetic Healthcare and endorsed by the PTEN Hamartoma Tumor Syndrome
Foundation and PTEN Italia, the symposium will offer state-of-the-art information to healthcare
providers treating patients with germline PTEN mutations and provide a forum for members of
the PHTS patient community to connect and learn about cutting-edge PTEN research as well as
clinical surveillance and management guidelines. PHTS is a rare, complex disorder affecting
multiple organs over the lifespan with differing manifestations based on age. Patients with a
PTEN mutation require lifetime follow-up for neurological concerns and cancer risk surveillance
as well as familial screening and evaluation. A comprehensive care model that includes both
pediatric and adult specialists familiar with this condition and prepared to provide optimal care is
necessary. Unfortunately, PHTS is not well known to many clinicians throughout the world. To
address this knowledge gap, the program is centered on the following learning objectives: (1)
describe current PTEN translational and clinical research, (2) apply research information about
PHTS to diagnosis, screening, surveillance, guidelines, patient needs, clinical features and
coordination of multidisciplinary team care and (3) demonstrate awareness and share education
about PHTS, leading to timely diagnosis, appropriate surveillance and improved patient
outcomes. Expert Cleveland Clinic and guest faculty will share research and case-based
presentations highlighting the advances of genetics and genomics of PHTS and the science of
PTEN. Topics include PTEN biology and therapeutics, neurodevelopmental disorders,
hereditary breast cancer, gynecological cancer, updates on PTEN research and clinical trials,
PTEN-related vascular anomalies, and stress and resilience in coping with PHTS. The program
also will incorporate a patient experience panel, which will provide the opportunity to hear
unique patient perspectives on PHTS. The symposium will be held as a live one-day event on
March 27, 2023, at the InterContinental Hotel and Bank of America Conference Center in
Cleveland, Ohio and will be available to virtual attendees via a livestream.

Public health relevance
Project Narrative: PTEN hamartoma tumor syndrome (PHTS), a rare genetic condition associated with an increased risk for certain cancers, benign growths and neurodevelopmental conditions, is not well known to many clinicians, which limits their ability to provide appropriate patient care for patients with PHTS and achieve optimal patient outcomes. The 6th Annual International PTEN Symposium: From Patient-Centered Research to Clinical Care, presented by Cleveland Clinic’s Genomic Medicine Institute and Center for Personalized Genetic Healthcare and endorsed by the PTEN Hamartoma Tumor Syndrome Foundation and PTEN Italia, seeks to provide providers across multiple specialties with education on the diagnosis, management and treatment of patients with PHTS. The symposium, which will be held on March 27, 2023, as a hybrid (in-person and virtual) event, features presentations by expert Cleveland Clinic and guest faculty that highlight the advances of genetics and genomics of PHTS and the science of PTEN as well as a patient experience panel.